Research Training in the Neurosciences

on Name Oxford, Gerry S. Anton, Eva Breese, George R. Brenman, Jay Carelli, Regina M. Cheney, Richard E. Crews, Fulton T. Crews, Stephen T. Deshmukh, Mohanish Dykstra, Linda PHS 398 (Rev. 05/01) Page 11. Use continuation pages as needed to provide the required information in the format shown below. Organization Role on